Translational Control of Host Environmental Stress Responses in Candida albicans

PROJECT SUMMARY/ABSTRACT
Candida albicans is a major human fungal pathogen responsible for a wide variety of systemic and mucosal
infections. Immunocompromised individuals, including organ transplant recipients, AIDS patients and cancer
patients on chemotherapy are highly susceptible to infection. A morphological transition from yeast to
filamentous cells and the ability to respond to a wide variety of host environmental stresses are critical for
pathogenesis. While transcriptional and post-translational mechanisms that mediate C. albicans filamentation
and stress responses have been well-characterized, considerably less is known about the role of translational
mechanisms. However, UME6, a key regulator of C. albicans morphogenesis, is controlled by a 5’ UTR-
mediated translational efficiency mechanism. The eIF4F translation initiation complex is important for binding
to the 5’ cap of mRNAs and contains helicase activity that unwinds complex secondary structures in 5’ UTRs to
promote ribosome accessibility. Fungal-specific C. albicans orthologs of the yeast eIF4E-binding proteins
(eIF4E-BPs) Eap1 and Caf20, which function as negative regulators of the eIF4F complex, were shown to
control morphogenesis and a variety of stress responses. Both C. albicans eIF4E-BPs are down-regulated in
response to membrane stress and orf19.7034 (the Eap1 ortholog) functions as a negative regulator of P-
bodies (translationally inactive cellular compartments) under multiple stress conditions. Orf19.7034 and the
eIF4E cap-binding protein, also control Ume6 protein levels in a 5’ UTR-dependent manner. Asc1, a key
virulence factor and phosphosignaling protein important for morphogenesis whose yeast ortholog forms a
complex with Eap1 to translationally control target genes, also regulates a variety of C. albicans stress
responses. We show genetic interactions between Asc1 and eIF4E-BPs with respect to control of morphology,
biofilm formation and/or stress responses. Using ribosome profiling, C. albicans morphogenesis and response
to the drug stress fluconazole were also shown to be under widespread global translational regulation that
does not simply parallel transcriptional control. Based on this evidence, and additional studies, our hypothesis
is that Asc1 and eIF4E-BPs function together to translationally regulate C. albicans morphology, stress
responses and virulence by modulating activity of the eIF4F complex in response to host environmental cues.
To address this hypothesis, we plan to: 1) determine how Asc1 and eIF4E-BPs control the ability to respond to
host filament-inducing and environmental stress conditions, 2) determine the mechanism by which Asc1 and
eIF4E-BPs control C. albicans morphogenesis and Ume6 expression, 3) determine the functional relationship
between Asc1 and eIF4E-BPs with respect to regulation of C. albicans target gene expression, pathogenesis
and virulence. These studies will provide a better understanding of translational mechanisms that control the
response of C. albicans to a variety of filament-inducing and host environmental stress conditions, and could
ultimately provide information leading to the development of new and more effective antifungals strategies.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Candida albicans is a major human fungal pathogen responsible for both mucosal and systemic infections in a wide variety of immunocompromised individuals. This proposal seeks to determine how translational mechanisms control the ability of C. albicans to tolerate a variety of different host environmental stess conditions and undergo filamentous growth, promoting virulence and pathogenicity. Ultimately, this study will provide new information leading to the development of novel and more effective strategies for the treatment of candidiasis.